MFRPS Maintenance New Jersey Department of Health

PROJECT SUMMARY/ABSTRACT
The Manufactured Food Regulatory Program Standards (MFRPS) establish a uniform
foundation for the design and management of state programs responsible for the regulation of
manufactured food facilities. The continued maintenance of these program standards will assist
federal and state programs to better direct their regulatory activities toward reducing foodborne
illness hazards in food plants.
Based on the New Jersey Department of Health 2023 Strategic Plan and MFRPS
Meeting report from FDA Development and Implementation Branch Staff, the program needs for
the cooperative agreement application funding include:
 Continue to enhance conformance with all Standards.
 Maintain an electronic inspection program for Field Staff.
 Annual meeting travel of key MFRPS managers & staff to participate in annual face-to-
face meetings and other initiatives supporting national and program specific
conformance with the MFRPS.
 Provide training to state staff conducting manufactured foods inspections.
 Obtain additional inspectional and IT related equipment for field staff.
If funded under this cooperative agreement application, New Jersey will continue to strive
toward maintenance with the MFRPS as we build capacity in a food safety program focused on
public health, while working in collaboration with FDA and other stakeholders as part of an
Integrated Food Safety System.

Public health relevance
PROJECT NARRATIVE The New Jersey Department of Health, Public Health & Food Protection Program will continue to maintain conformance with the Manufactured Food Regulatory Program Standards (MFRPS) as we build capacity in our food safety program focused on public health, while working in collaboration with FDA and other stakeholders as part of an Integrated Food Safety System. The maintenance and continued implementation of the standards will provide the highest quality manufactured food inspection program as well as further enhancing food safety by quickly identifying foodborne illness and injury hazards.